Development of a web-based predictive model of nanoparticle delivery to tumors by integrating physiologically-based pharmacokinetic modeling with artificial intelligence

PROJECT SUMMARY AND ABSTRACT
Many studies have shown that nanoparticle (NP)-based drug formulations are effective in the diagnosis and
treatment of cancer in lab animals, but the translation of animal results to clinical success is low. This is partly
due to two fundamental challenges in this field, which are low delivery efficiency of NPs to the tumor and lack
of a robust computational model to account for NP pharmacokinetic (PK) differences across species and thus
allow one to predict tumor delivery and extrapolate the results from animals to humans. The objective of this
proposal is to develop a robust, validated, and predictive generic physiologically based pharmacokinetic (PBPK)
model for NPs in male and female tumor-bearing mice. Our hypothesis is that tissue distribution and tumor
delivery of different NPs can be predicted with a generic PBPK model by training with hundreds of datasets
with advanced mathematical methods, such as Bayesian-based Markov chain Monte Carlo (MCMC)
simulations and/or artificial neural network (ANN) methods using species- and sex-specific physiological and
NP-specific physicochemical parameters. Three specific aims were designed to achieve this objective. Aim 1:
To develop a Bayesian-based robust generic PBPK model for NPs in male and female tumor-bearing mice.
Aim 2: To develop a Bayesian-based robust and predictive generic PBPK model for NPs in male and female
tumor-bearing mice by incorporating artificial intelligence. Aim 3: To validate and optimize the Bayesian-PBPK-
ANN model with new experimental data and convert it to a web-based interface. In Aim 1, a Bayesian-MCMC
method will be used to ensure model parameters are rigorously optimized and unbiased. In Aim 2, we will test
the hypothesis that incorporation of artificial intelligence methods, such as ANN will significantly improve the
prediction accuracy, efficiency, and applicable domain of the Bayesian-PBPK model. In Aim 3, we will conduct
PK and tissue distribution experiments in tumor-bearing mice to validate our model. Recently, we published a
simple PBPK model for NPs in tumor-bearing mice and a Nano-Tumor Database that contains 376 datasets.
These studies make this proposal highly feasible. This project is novel because: (1) it is a new application of
Bayesian-MCMC and ANN methods in cancer nanomedicine; (2) it provides a tool to compare potential sex
differences in NP tumor delivery; (3) the model will be “predictive”, which makes it different from previous
studies that were mostly “correlative” analysis; and (4) the model will be converted to a web-based interface to
facilitate its application to a wider audience. This project is significant since it addresses a crucial problem of
low delivery efficiency of cancer nanomedicines, which has been a critical barrier to progress over the last 20
years. This project has broad impacts because it will greatly improve our fundamental understanding of the key
factors of NP tumor delivery and any potential sex-dependence, and will provide a tangible tool to improve the
design of NPs with higher tumor delivery efficiency to accelerate clinical translation of cancer nanomedicines
from animals to humans, and also reduce/eliminate animal experimentation in nanomedicine studies.

Public health relevance
PROJECT NARRATIVE In the field of nanomedicine, there are many laboratory studies that have shown nanoparticle-based new drug formulations are effective in treating cancer in mice, but the translation of animal results to clinical success in humans is limited, in part, due to low delivery efficiency of nanoparticles to the tumor and lack of a robust computational model that can predict the tumor delivery efficiency of nanoparticles and extrapolate the results from animals to humans. This project is relevant to public health because the knowledge gained from the proposed research will improve our understanding of the key determinants of tissue distribution and tumor delivery of nanoparticles, which are essential for the design of effective nanomedicines. In addition, the proposed research will create a publicly available web-based interface that allows researchers to predict organ and tumor delivery efficiency of nanoparticles, thereby reducing or eliminating animal experimentation in nanomedicine studies and to accelerate clinical translation of nanoparticle-based anticancer drug formulations to benefit cancer patients.